Building a culture of health in the green: Participatory learning and action to address air and soil quality in rural underserved communities

PROJECT SUMMARY
The Integrated Environmental Science and Health Risk Laboratory, in collaboration with multiple
Arizona partners, propose to launch the project, “Building a culture of health in the green:
Participatory learning and action to address air and soil quality in rural underserved
communities”. Our overall goal is to create a national deep engagement learning model of
Science, Technology, Engineering, Arts and Math (STEAM) education that empowers students
as environmental health advisory board members, photographers, scientists, and designers living
in environmental justice (EJ) communities. EJ communities refers to areas affected by
disproportionate exposure to environmental hazards and increased vulnerability to those hazards.
There are fundamental and critical challenges that exist in environmental justice communities.
Youth growing up in these spaces need the preparation to navigate through these challenges and
be the future pillars of structural change. Students will acquire the tools, skills and support needed
to (1) interpret intersectionality and environmental data and (2) communicate project results and
recommend actions at local, regional, and national levels. The proposed project centers on the
social and environmental factors that affect health and justice for 8th - 12th graders in rural Arizona
communities with significant environmental health hazards posed from historical or active
resource extraction activities. Intersectionality and environmental health and data literacy are
essential for deriving meaning from the results of scientific inquiry. Potential outcomes for the
proposed project are increased understanding and integration of intersectionality, environmental
health (specifically air and soil quality), and data literacy among both youth and researchers,
and the application such information to achieve social justice and health equity in EJ communities.
This research education program aims to leverage intersectionality’s transformational power and
help move the collaborating EJ communities closer to achieving social justice and health equity.
Through the approach and rigorous learning research, the outcomes of this work will provide the
evidence-base needed for building a culture of health in the green.

Public health relevance
PROJECT NARRATIVE The long-range goal of the “Building a Culture of Health and Action” Project is to create a national deep engagement learning model of Science, Technology, Engineering, Arts and Math (STEAM) education that engages 8th - 12th graders and provides them with the tools, skills and support to document, reflect upon, and communicate issues of concern (through an advisory board and Photovoice); collect soil and dust samples (through co-created citizen/community science); and make sense of data so that their results can inform actions at the local, regional, and even national level (through data visualization and environmental communication). The proposed educational program is focused on social determinants of health and environmental health in rural, medically underserved communities in Arizona that neighbor resource extraction. In the context of learning, environmental health education objectives include understanding: (1) how advisory boards can foster the development of critical thinking and communication skills; (2) how a summer certification program can increase environmental health literacy (EHL); (3) how an equity-centered community design approach to data sharing strategies can build a participant’s EHL; and (4) how to successfully broaden participation in STEAM learning by historically underrepresented individuals living in environmentally compromised spaces.